Resolving Spatiotemporal Determinants of Cell Specification in Corticogenesis with Latent Space Methods

Project Summary
High-throughput profiling of hundreds of thousands of cells in the central nervous system (CNS) is currently
underway. One of the goals of the BRAIN initiative is to build a census of cell types in the CNS, however
previous work in single cell RNA sequencing (scRNAseq) has demonstrated that reliance on small collections
of marker genes for cell type/state/position classification is insufficient to account for the dynamic nature of and
variation in cellular classes/states. Previous work from both myself and others has demonstrated that latent
space methods identify low dimensional patterns from high dimensional profiling data can discover molecular
drivers of cell types and states in scRNAseq. However, the use of algorithms untethered to biological
constraints or not extensively functionally validated can lead to the arbitrary delineation of cell class/state and
the trivial designation of “novel” cell types. As proper development of the CNS requires precise regulation and
coordination of spatial and temporal cues, the overall objective of this application is to develop analytic and
experimental methods that integrate spatiotemporal information with scRNAseq to learn meaningful latent
spaces. Specifically, I will 1) generate a comprehensive collection of transcriptional signatures for spatial
features of the brain, 2) build dimension reduction software to encode spatial and cell cycle information to
account for the highly specific organization of cells in the CNS, 3) derive a statistic, projectionDrivers, that
allows for quantification of the gene drivers of differential latent space usage, and 4) define a statistic,
proMapR, that will tell you the probability of a cell existing in a particular location in the brain at a given point in
time from the cell's transcriptional signature. The ability to define and validate biologically meaningful latent
spaces not only enables multiOmic data integration and exploratory analysis of scRNA-seq data via the
massive amount of publicly available data, but also lays the groundwork for multimodal data integration—a
necessary next step to characterize how individual cells and complex neural circuits interact in both time and
space.

Public health relevance
Resolving Spatiotemporal Determinants of Cell Specification in Corticogenesis with Latent Space Methods Applicant: Genevieve Stein-O’Brien, PhD MHS Proper development of the brain requires precise regulation and coordination of spatiotemporal cues. We hypothesize human genetic variation manifests phenotypic differences by introducing small biases in spatiotemporal determinants that have accumulated effect over development. To test this hypothesis, we build novel computational and experimental tools to resolve transcriptional regulation of anatomical identity (space) and cell cycle length (time) in the brain and apply these tools to induced pluripotent stem cells from ALS patients in a model of brain development to show the effect of genetic background.